Systematically Investigate Anti-Cancer Drug’s Modulation on T Cells in Tumor Microenvironment

SUMMARY: Despite the transformative impact of immune checkpoint blockade (ICB) therapies in cancer
treatment, the persistent challenge of low response rate and high risk of ICB resistance necessitates innovative
approaches. Emerging studies acknowledge the immunomodulatory effects of conventional chemotherapies and
small molecule inhibitors. However, due to the limited insight of interactions between drug treatment and tumor
microenvironment, the synergy potential of most anti-cancer drugs with immunotherapy are not systematically
evaluated. In our recent publication, we proposed a novel chemo-immunotherapy synergism prediction algorithm
based on the post-treatment transcriptomic profiling of tumor cells and cancer patients. In this proposal, we seek
to expand our approach to exploring the chemo-immunotherapy synergisms specifically through the lens of
immune cell populations within tumor microenvironment. By comprehensively profiling pharmacologically or
genetically perturbed T cells and analyzing their interactions with tumor cells, we seek to identify novel drug
combinations that can overcome ICB resistance by modulating T cell activities. To achieve this goal, we have
designed three specific aims: AIM I (K99) will conduct in silico screening of anti-cancer drugs that can impact T
cell effector function, activation, stemness and proliferation; AIM II (K99-R00) will conduct single-cell CRISPR
KO (scCRISPR-KO) screening of anti-cancer drug targets that can regulate T cell anti-tumor immunity; based
on the Perturbed T Cell Signature Compendium (PerTCellS) built upon AIM I and II, AIM III (R00) will construct
a T cell-centric ICB response signature and develop a novel synergy prediction algorithm to identify anti-cancer
drugs that can boost ICB therapy through priming T cells. Our approach will provide a novel and comprehensive
insight of interactions between anti-cancer drugs and T cell functionalities, which will facilitate the discovery and
the repurposing of chemotherapy agents and small molecular inhibitors to enhance immunotherapy efficacy.

Public health relevance
NARRATIVE: The goal of this project is to systematically identify anti-cancer drugs that can enhance T cell activities in tumor microenvironment and synergize with immune checkpoint blockade (ICB) therapy. We hypothesize that a comprehensive transcriptomic profiling of pharmacological or genetically perturbed T cells, coupled with an exploration of their interactions with tumor cells, will unveil the anti-cancer drugs that can prime T cells for enhanced ICB treatment benefits. Our three specific aims encompass in silico screening of drug candidates, single-cell CRISPR KO screening of drug targets, and integration of pharmacological and genetic screens to identify novel drug combinations to overcome immunotherapy resistance in cancer.